Center for Multi-Scale Multi-Omic Human and non-human primate Brain Atlas

Project Summary
A detailed understanding of the functional, anatomical and molecular architectures of brain cells and
their brain-wide organization is essential for interrogating normal human brain function and disease
states. Extensive efforts have been made toward mapping brain cells through various approaches,
resulting in invaluable databases that are yielding new insights. However, we still lack comprehensive
human brain atlases that capture multi-level properties of individual cells while adequately representing
human demographic diversity and individual variability. The goal of this proposal is to create fully
integrated three-dimensional (3D) human and non-human primate (NHP) brain cell atlases at
subcellular resolution by simultaneously mapping brain-wide function, structure, and high-dimensional
features (e.g., proteomic, transcriptomic, spatial, morphological, microenvironment and nanoscopic
information) of cells acquired from the same whole brains with complete coverage of all brain regions.
Our team will accomplish this by seamlessly integrating multimodal data from state-of-the-art
functional (for NHP brains), structural, diffusion MRI, and multiscale 3D proteomic/transcriptomic
imaging technologies. Using the scalable technology pipelines, we will perform proteomic and
transcriptomic imaging of (1) human brains acquired from a large number of demographically
representative donors and (2) functionally characterized non-human primate brains. The proposed work
will create the most comprehensive 3D human and NHP brain atlases to date, with unprecedented
resolution and completeness. The atlases will establish inter-species homologies essential for the
translation of insights derived from animal models to humans, and aid in identifying the cellular and
molecular underpinnings of human cognition and susceptibility to disease. Additionally, the
unprecedented, multiscale multi-omic datasets acquired from a large number of demographically
representative human donors will enable population level inter-individual variation study and allow
baseline characterization of cellular and subcellular features, providing an immediately useful reference
frame for the research community to study disease-specific changes in cell composition, spatial
distribution, and subcellular architectures. Finally, our team will work closely with existing BICAN
centers to maximize synergy and utilization of scarce brain materials and enable true multimodal data
integration.

Public health relevance
Brain function emerges from an ensemble of multi-scale interactions, ranging from individual cells to functional circuitries, therefore, to truly understand the brain functions (and its dysfunctions), it is crucial to take an integrative, multimodal approach to aggregate molecular, cellular, structural, and functional information. Recent technological breakthroughs in neuroimaging, single-cell/spatial genomics, transcriptomic/proteomic imaging technologies will enable this center aims to generate comprehensive, spatially-resolved brain atlases of human, rhesus macaque, and marmoset that bridge the multi-scale features and integrates inter-species homologies and population variance with particular care to equitable demographic representation. The primary output of this proposal will have significant impact on public health by providing an immediately useful series of reference atlases, experimental and analytical tools for the community that will accelerate translation of insights derived from animal models to human, and to study disease-specific features in cell composition, spatial patterns, and molecular architectures with unprecedented resolution.